CTSA K12 Program at Harvard Medical School

PROJECT SUMMARY
The goal of the Harvard Catalyst K12 program is to create an environment for early-stage clinical and
translational (CT) investigators that facilitates their career development and encourages paradigm-shifting,
diversity-focused interdisciplinary collaboration and team-based research approaches to advance CT science.
Since its founding in 2008, the Harvard Catalyst KL2 program has served as the cornerstone across Harvard
Medical School (HMS) and its affiliated academic medical centers for training our most outstanding early-stage
CT investigators. Given the demonstrated success of the KL2 program since 2008, the new K12 program will
build on the KL2 program's strengths. The new K12 program will specifically seek to help train and develop the
future leaders of CT science by leveraging the Harvard Catalyst cores and integrating the scholars into the
broader CT infrastructure at Harvard Catalyst and the CTSA consortium. In addition, through dedicated funding
from the HMS-affiliated AMCs, the K12 program will continue to be paired with the Catalyst Medical Research
Investigator (CMeRIT) program to further enrich the K12 learning environment. Moreover, through the continued
growth and expansion of the Clinical and Translational Research Academy, a supporting infrastructural
element of Harvard Catalyst, the K12 will create a community for CT investigators and enhance the transition
to independence for all K awardees across HMS. Finally, the K12 program will work closely with the Harvard
Catalyst Cores and other NIH-funded programs at HMS to enhance the research capability, competency and
performance of all K12 awardees with a new focus on translational science. The overarching objective of the
program is to ensure and nurture the sustainable careers of early-stage CT investigators and ultimately advance
translational science. The K12 program will offer sustained protected time for scholars to advance their CT
research, overseen by a primary mentor and co-mentor and now further enhanced by a dedicated mentorship
committee, including a separate career mentor to provide outside input on broader career goals. Training will
include the use of new courses and programs, including our monthly Translate Together curriculum, that covers
the broad translational spectrum and focuses on developing innovative solutions that improve human health. It
will also include the development of individualized career development programs, leadership training, visibility
through participation in the national CTSA Visiting Scholar Program, and mentor/mentee training, to ensure the
success of each scholar as a translational scientist as envisioned by NCATS. The K12 will also seek to educate
scholars on the importance of community engagement for the execution of effective CT research to ensure the
highest quality science can be completed. In a related context, building on our earlier success in improving the
diversity of the KL2 program, we will continue several diversity and inclusion initiatives both to ensure that we
have a vibrant and diverse group of scholars but also to ensure that all scholars are fully educated on diversity
as a critical feature of all successful CT research endeavors.

Public health relevance
PROJECT NARRATIVE The Harvard Catalyst K12 Program will be the premier educational opportunity at Harvard Medical School and its associated academic medical centers for early-stage investigators seeking to pursue a career in clinical and translational research. The program will build off the already successful KL2 program, which launched in 2008. It will also embrace many new initiatives, including enriched mentoring, training in translational science, a strong and directed effort to pursue diversity and inclusivity at every level, and a range of new educational opportunities and experiences to ensure that the highly promising physician scientists of today can become the leading medical innovators of tomorrow.